Mechanisms of Juxta-Cardiac Field Progenitors

Project Summary
The heart is composed of a broad range of diverse cardiac cell types, which organize into distinct cardiac
structures that coordinately regulate cardiac function and circulation throughout the body. Despite efforts
devoted toward understanding how these cardiac cell types are created in order to develop potential human
cardiac therapies and/or illuminate underlying mechanisms/etiologies of congenital heart disease (CHD), our
understanding of how diverse cardiac cell types emerge from developmental heart field progenitors, and how
they organize into heart structures remains to be fully defined. Thus, we propose to identify and investigate the
cardiovascular developmental regulators and gene regulatory networks that direct the development of Juxta-
Cardiac Field (JCF)-derived cardiovascular cell types creating the mammalian heart. Toward this end, a multi-
disciplinary experimental and computational systems biology approach will be employed to: (1) examine the
contribution of JCF progenitors to the developing heart, (2) investigate how JCF progenitors differentiate into
specific cell types contributing to heart development and (3) investigate whether mechanisms in JCF
development are conserved in human heart development.

Public health relevance
Project Narrative This proposal seeks to illuminate the cardiogenic cellular hierarchy and the gene regulatory networks that determine the origins and fates of Juxta-Cardiac Field (JCF) cardiovascular progenitor cells during heart development. Results from these studies will yield new insights into how disrupted cardiovascular regulatory networks lead to congenital heart disease and how they may be modified to develop treatments to improve patient outcome.